Investigating Environmental Microplastic Particles and Pollutant Interactions in a Changing Environment

Abstract – Project 2
The objectives of Project #2 are to improve our understanding of human exposure to environmental microplastics
and to learn how persistent organic pollutants (POPs) and metal ions interact with microplastics to modify toxicity.
Microplastics are ubiquitous environmental pollutants. Though humans are chronically exposed to microplastics,
the literature pertaining to mammalian health risks is sparse. The preponderance of literature focuses on
enumerating the size, shape and color of environmental microplastics and on examining the toxicity of
commercial pure plastic particles, principally polystyrene microspheres, on aquatic organisms. Studies find that
microplastic toxicity increases with decreasing microplastic size, however, collecting environmental microplastic
<100 µm in diameter for testing is challenging, so it is rarely done. Recently, we showed that nanomembrane
filter technology is able to filter microplastics in size ranges that are smaller than is typically feasible and is more
likely to breech epithelial barriers to interact directly with cells. Furthermore, it is known that environmental
microplastics adsorb POPs and/or metal pollutants, yet little is fundamentally understood about how
microplastic/pollutant interactions may alter toxicity. This project seeks to remedy these knowledge gaps by
enumerating the presence of microplastics <100 µm in diameter in Lake Ontario water and in airborne Lake
spray and testing the microplastic enriched in the retentate for cytotoxicity/bioactivity including aryl hydrocarbon
receptor activity and endocrine disrupting properties. We will investigate microplastic interactions with POPs
and metals that are abundant in Lake Ontario as a function of temperature to account for seasonal variations
and climate change. The overall hypothesis of this project is that filtered debris from Lake Ontario water and
airborne Lake spray will exhibit biological activity and that pollutant-MP interactions will alter bioactivity
depending on MP composition and temperature.

Public health relevance
Narrative – Project 2 The objectives of Project #2 are to improve our understanding of human exposure to environmental microplastics in Lake Ontario near shore water and air. We will learn about the human health impacts associated with this exposure. Studies will also reveal how microplastic particles interact with pollutants to modify bioactivity.